Cellular and Developmental Biology of Coxiella burnetii

A biphasic developmental cycle whereby highly resistant small cell variants (SCV) are generated from large cell variants (LCV) is considered fundamental to C. burnetii virulence. We conducted a proteome analysis of C. burnetii developmental forms to provide insight into their unique biological and immunological properties. Silver-stained gels of SCV and LCV lysates separated by two-dimensional (2-D) gel electrophoresis resolved over 675 proteins in both developmental forms. Forty-eight proteins were greater than two-fold more abundant in LCV than SCV with six proteins greater than two-fold more abundant in SCV than LCV. Four and 15 upregulated proteins of SCV and LCV, respectively, were identified by mass spectrometry and their predicted functional roles are consistent with a metabolically active LCV and a structurally resistant SCV. One dimensional and 2-D immunoblots of cell form lysates probed with sera from infected/vaccinated guinea pigs and convalescent serum from human acute Q fever patients, respectively, revealed both unique SCV/LCV antigens and common SCV/LCV antigens that were often differentially synthesized. Antigens recognized during human infection were identified by mass spectroscopy and included both previously described immunodominant proteins of C. burnetii as well as novel immunogenic proteins that may be important in the pathophysiology of clinical Q fever and/or the induction of protective immunity.[unreadable] [unreadable] C. burnetii actively participates in the biogenesis of its parasitophorous vacuole (PV) by synthesizing proteins that modulate vesicular interactions and other host processes. Functional characterization of these molecules will yield important insight into C. burnetii-host interactions, and we are currently using there complementary strategies to achieve this goal. The first strategy employs subcellular fractionation and proteomics. C. burnetii and host factors that regulate PV formation are likely localized to the PV membrane; therefore, their identification would be aided by an efficient method to isolate this vacuole. To this end, we developed a method to separate intact PV from host cell material that relies on fusion of the vacuole with latex bead-containing phagosomes (LBP). Transmission electron microscopy confirms the isolation of intact PV containing latex beads. Immunoblotting demonstrates that C. burnetii PV lysates are dramatically enriched for the late endosome/lysosome markers LAMP-1 and LAMP-2 when compared to total host cell lysates. Conversely, PV preparations are devoid of p62 and GM130, markers of the nucleus and Golgi apparatus, respectively, indicating effective separation of the vacuole from these host cell compartments. Two-dimensional gel electrophoresis and immunoblotting reveal distinct protein differences between C. burnetii PV and LBP that may refect specific recruitment of C. burnetii effectors to the PV membrane. The second approach exploits the presence of a specialized Coxiella type IV secretion system with close homology to that of its relative Legionella pneumophila. We have successfully used Legionella as a surrogate host and the calmodulin-activated adenylate cyclase (Cya) screen to identify candidate Coxiella type IV secretion substrates. The Cya screen relies on the fact that elevated adenylate cyclase activity is only observed when a Cya-Coxiella fusion protein is delivered to the host cytoplasm. Using this strategy, we have now identified 12 Coxiella proteins that are secreted by Legionella in a type IV-dependent fashion. These are currently being functionally characterized. The final strategy relies on secretion of effectors by Coxiella in a cell free medium. Axenic (host cell free) buffers have been described that activate C. burnetii metabolism in vitro, but metabolism is short-lived with bacterial protein synthesis halting after a few hours. By systematically evaluating complex nutrient mixtures, we developed an axenic medium termed Complex Coxiella Medium (CCM) that supports robust and sustained C. burnetii metabolic activity in the form of protein and ATP synthesis. Moreover, we have also shown that maximal respiratory chain activity occurs in an atmosphere of 2.5% oxygen, consistent with microaerophilic metabolism in this bacterium. Not only does the robust metabolic activity of C. burnetii in CCM provide a potential means to identify secreted Coxiella proteins, it also represents a powerful in vitro tool to study metabolic responses to stresses that are likely encountered by the pathogen within the host cell. [unreadable] [unreadable] A potential target of secreted C. burnetii effector molecules is the apoptotic cell death pathway. Indeed, in all cell types examined, C. burnetii carries out a lengthy infectious cycle with minimal cytopathic effects. We recently demonstrated that C. burnetii inhibits apoptotic cell death during infection of human THP-1 monocyte-derived macrophages and primary monkey alveolar macrophages. C. burnetii-infected cells show significant protection from death relative to uninfected cells following treatment with staurosporine, a potent inducer of mitochondrial-mediated intrinsic apoptosis. This protection correlates with reduced cleavage of caspase-9, caspase-3, and poly (ADP-ribose) polymerase, all proteolytic events that occur during apoptosis. In addition to intrinsic apoptosis, C. burnetii-infected cells are also protected from extrinsic apoptosis induced by TNF-alpha. Infected cells demonstrate sustained activation of the pro-survival serine/threonine kinase Akt that may provide protection from cell death via both intrinsic and extrinsic pathways. Infected cells display increased synthesis of the anti-apoptotic proteins A1/Bfl-1 and c-IAP2 and altered expression of multiple anti- and pro-apoptotic genes. Collectively, these data suggest that C. burnetii stimulates host cell survival signaling and modulates both extrinsic death receptor-mediated and intrinsic mitochondrial-mediated apoptotic pathways to inhibit host cell death. This is likely a pathogenic strategy that ensures a stable, intracellular niche for the course of the pathogens infectious cycle. The observation that inhibition of apoptosis requires C. burnetii RNA and protein synthesis strongly implicates a role for secreted pathogen effector molecules in this process. [unreadable] [unreadable] The intracellular lifestyle of C. burnetii has led to the assumption that cell-mediated immunity is the most important immune component for protection against this pathogen. However, passive immunization with immune serum can protect nave animals from challenge with virulent C. burnetii, indicating a role for antibody (Ab) in protection. The mechanism of this Ab-mediated immunity (AMI) is unknown. We have previously demonstrated that virulent C. burnetii infect and replicate within dendritic cells (DC) without inducing their maturation or activation. We have new data showing that uptake of Ab opsonized virulent C. burnetii by human monocyte-derived and murine bone marrow-derived DC causes these cells to mature and produce inflammatory cytokines. Ab opsonization increased the rate C. burnetii uptake by DC, but had no effect on pathogen replication. The effect of Ab opsonized C. burnetii on DC was Fc receptor(FcR)-dependent as evidenced by a reduced response of DC from FcR knockout (FcR k/o) compared to C57Bl/6 (B6) mice. To address the potential role of FcR in AMI in vivo, we compared the response of passively immunized FcR k/o mice to the B6 controls. Interestingly, AMI was unaltered in FcR k/o mice indicating that this phenomenon is not FcR dependent in vivo. Our results indicate that, despite the important role of FcR in the response of DC to Ab-opsonized C. burnetii in vitro, AMI in vivo is FcR independent.